Smartphone-Based Solutions for Prospective Memory in Mild Cognitive Impairment and Dementia

Abstract:
Alzheimer’s disease and related dementias lead to marked declines in daily functioning, independence, and
quality of life. One of the earliest cognitive changes in these conditions is impairment in prospective memory,
or the ability to remember future intentions such as taking medications at a given time. Prior intervention
studies that targeted prospective memory used mnemonic strategies or cognitive training, but these
approaches resulted in modest gains in clinical populations. By contrast, our Stage I pilot trial indicated that
smartphone-based memory aids (reminder apps) can be used by persons with mild cognitive impairment and
mild dementia to improve both subjective and objective prospective memory performance. Having established
feasibility and acceptability in the Stage I pilot study, we will now test for efficacy, durability, and generalizability
of benefits across diverse samples in a Stage II randomized controlled trial. We will recruit 200 participants
with mild cognitive impairment or mild dementia, half of whom will be from digitally-disadvantaged backgrounds
(low socioeconomic status, rural, or historically underrepresented groups). These populations are well-
captured by our clinical catchment areas. Participants will complete baseline assessments and then be
randomly assigned to a smartphone reminder app intervention or an active control condition that uses a paper-
based memory support system. Across a 4-week intervention period, participants will complete both patient-
selected and experimenter-assigned prospective memory assessments and receive booster training sessions
to promote self-efficacy with the intervention/control system. We will assess durability of effects at 3-month and
6-month follow-up sessions. It is unknown whether smartphone-based or paper-based approaches will be
better at supporting prospective memory across 6 months in older adults with cognitive impairment and digital
disadvantages. However, based on pilot data, we anticipate that the reminder app will be especially beneficial
to prospective memory because it provides automated reminders, allows care partners to “push” reminders
and events, and it includes daily alerts to use the app. As a secondary aim, we will simultaneously enroll family
or friend study partners to collect informant ratings, track how much study partners assist the participants, and
determine whether improving prospective memory in patients improves quality of life in study partners (e.g., by
reducing the double to-do list burden of remembering for themselves and for care recipients). As a third aim,
we will integrate quantitative and qualitative data to identify barriers and facilitators to smartphone interventions
in digitally-disadvantaged individuals who have historically been underrepresented in technology and dementia
research. This research will advance understanding of technology usage in older adults, inform whether
smartphone-based reminder apps are effective and durable relative to established paper-based approaches for
prospective memory, and provide the foundation for personalized cognitive medicine interventions.

Public health relevance
Project Narrative Difficulties with prospective memory, such as remembering to take medications, represent a signature decline in mild dementia, worsen quality of life and independence, and add burden to care partners. In this randomized controlled trial, individuals with mild cognitive impairment and mild dementia will train to use either a smartphone-based or paper-based memory strategy to compensate for daily prospective memory challenges. This work will help preserve independent functioning in persons with cognitive impairment and reduce burden on families impacted by dementia.